Core--Research histology facility

Description: (Applicant's Description) The Research Histology Shared Facility will meet the following objectives in support of Cancer Center Research. The Facility will provide reliable detection methods for antigenic proteins in a timely manner. It will provide high quality histology studies and apoptotic cell detection in studies pertaining to cancer research. Dr. Tung, the facility's director, will participate as a consultant in experimental design, data interpretation and data presentation pertaining to pathologic studies of Cancer Center members. In addition, the Facility will develop new and adopt existing techniques for detecting antigenic proteins of contemporary interest using new reagents that are relevant to cancer research.